Quinolinate-induced immune suppression in glioblastoma

ABSTRACT
Recent advancements using immune checkpoint inhibitors designed to target tumor-mediated
immune tolerance have revolutionized cancer therapy. Unfortunately, these clinical successes
have not translated to glioblastoma (GBM), which continues to be an invariably fatal malignancy
with limited treatment options. One of the leading thoughts in the field explaining this lack of
clinical benefit in GBM is that these agents are acting upon the wrong target. Tumor-associated
macrophages (TAMs) appear to represent the primary immune cells contributing towards the
immune suppressive microenvironment in GBM, vastly outnumbering T cell infiltration. Hence,
there is considerable interest in developing therapeutic strategies designed to target M2 TAMs or
revert their polarization to enhance antitumor immunity. We discovered the accumulation of
quinolinate (QA), a downstream intermediate of tryptophan metabolism, as a previously
undescribed metabolic node in GBM. Through a series of investigations, we went on to
demonstrate the potent ability of QA to sculpt the GBM immune landscape by polarizing
macrophages towards the immune suppressive M2 phenotype. Potent anti-tumor activity was
observed when tested in GBM lines grown intracranially, supporting the therapeutic potential of
targeting QA metabolism in GBM. In this proposal, we now seek to define mechanisms
contributing towards QA-mediated macrophage polarization (Aim 1), extend studies evaluating
the immunologic/metabolic consequence of targeting QA in GBM (Aim 2), and identify rational
combinatorial strategies designed to exploit inhibition of QA-induced immune suppression (Aim
3). If successful, these results would offer a previously unrecognized window into the complex
metabolic interplay between tumor and immune cells in the GBM microenvironment, its functional
consequence on immune suppression, and framework for the identification of novel therapeutic
strategies in this aggressive malignancy with limited treatment options.

Public health relevance
Project Narrative Glioblastoma continues to be a uniformly fatal malignancy despite aggressive therapy. The proposed studies are designed to understand how changes in tumor metabolism can lead to an immune suppression in an effort to identify novel treatment regimens for this aggressive form of cancer.